CTSA Postdoctoral T32 at the University of Michigan

The Michigan Institute for Clinical and Health Research (MICHR) at the University of Michigan seeks to develop a new postdoctoral T32 training program to prepare early-stage postdoctoral fellows for careers in translational science and research. This two-year program emphasizes training in interdisciplinary team science that crosses departments and disease states. Recruitment centers on non-clinically trained basic scientists from biomedical, social, or data science disciplines. We also endeavor to recruit doctoral-level allied health professionals (e.g., postdoctoral individuals trained in nursing, pharmacy, physical therapy, and social work) that traditionally have had few options for advanced translational research training. Five trainees are appointed per year. Each trainee has a structured mentoring team that guides their professional and scientific development. This team includes Scientific Mentors, a MICHR Advocate from a different field that serves as a neutral third party, and a Near-Peer Mentor. Trainees and their mentoring team undergo didactic mentor training. Through the following Specific Aims, this program works synergistically and purposefully with our K12 and predoctoral programs to fully integrate with MICHR's mission to improve the lives of individuals and their communities through clinical and translational research: 1) Provide postdoctoral trainees with precision preparation for a career in translational science, including training on the fundamental characteristics of a translational scientist, participation in a Translational Immersion Experience with patients, clinicians, and/or policymakers to improve their understanding of the conditions they study, and through participation in the MICHR Career Development Studio, training in leadership and practical skills required to obtain and manage a research program; 2) Strengthen and expand the professional networks of postdoctoral trainees through networking and team science training, one-on-one interviewing assignments, and frequent networking opportunities with leading content experts; and 3) Prepare postdoctoral trainees to be versatile communicators with training in critical verbal and visual communication skills, including communicating via social media and with the press, and participation in MICHR Writing Squads and its K Writing Workshop to hone their written communication skills. Trainees will have access to the MICHR Implementation ToolBox, a suite of educational materials to support protocol implementation, and our M-COMPASS career development platform that provides trainees with self-paced training modules for incorporation into individual development plans.

Public health relevance
The Michigan Institute for Clinical and Health Research at the University of Michigan seeks to develop a new postdoctoral T32 training program to prepare early-stage postdoctoral fellows for impactful careers in translational science and research. Trainees receive personalized support for their training needs, multi-level training to enhance their professional networks, communication and dissemination training for different audiences. The overall objective of this training program is to help form the next generation of investigators that strive to improve the lives of individuals and their communities through translational science and research.